EVALUATION OF IVIG AND ZIDOVUDINE IN CHILDREN WITH SYMPTOMATIC HIV INFECTION

This protocol evaluates the safety, tolerance, and efficacy of AZT plus IVIG versus AZT plus placebo in children with symptomatic HIV infection, excluding children with LIP alone.